Evaluation of an implantable microdevice for rapid cancer drug screening directly in T cell lymphoma patients

Project Summary/Abstract:
Advanced cutaneous T cell lymphoma (CTCL) and peripheral T cell lymphoma (PTCL) have very poor survival
due to limited effective treatments. Three major obstacles have stalled drug development: 1) the low number of
patients with each T-cell lymphoma (TCL) subtype, which limits sample availability and clinical trial enrollment;
2) genetic and tissue microenvironment variability across subtypes; and 3) a lack of cellular and animal models
to test immunotherapies. Thus, there is a major scientific gap in the development of new treatments for TCL.
Here, we propose the use of an innovative implantable microdevice (MD), smaller than a grain of rice, that is
placed directly into a patient's cancerous lesion to screen drugs and to identify the most effective cancer drug
to treat TCL on a personalized level. Our MD delivers up to 20 drugs of any class into non-overlapping regions
of a tumor. It is delivered into the skin with a small needle and retrieved in 3 days by excising the device along
with a few millimeters of surrounding cancer tissue with a standard skin biopsy tool. This device allows testing
drugs directly inside the living tumor with microdoses, thereby avoiding the risk of systemic side effects. Drug
sensitivity is determined by histologic assessment of the tumor surrounding the device. The MD and the
method for processing and analyzing tissue has been validated across multiple cancer types in mouse models
and is being evaluated in an ongoing pilot study in breast cancer. The specific aims of these studies will be to:
i) determine the safety and feasibility of implanting and retrieving the MD in skin lesions of TCL; ii) assess local
responsiveness of TCL to cancer treatments delivered via the MD through microscopic assessments using
highly multiplexed cyclic immunofluorescence, a novel platform capable of characterizing subcellular changes
in the native immune microenvironment following drug treatment with over 30 markers, and iii) correlate
genetic abnormalities of TCL with drug response to identify potential biomarkers of response and to determine
if the MD can be used to predict clinical response by correlating the local tissue response to drug with a
patient's clinical response to the same drug when given systemically. We hypothesize that in situ tissue
profiling of drugs in TCL can predict systemic responses to standard of care therapies and therefore can serve
as a rapid screen for multiple investigational single or combination treatments. Additionally, genomic and
immunophenotypic analysis of tumors may assist in identification of predictive biomarkers of treatment. The
results of our studies will focus clinical trial efforts toward the most promising treatment strategies and usher in
the era of precision medicine in TCL.

Public health relevance
Project Narrative: Advanced cutaneous T cell lymphoma (CTCL) and peripheral T cell lymphoma (PTCL) have very poor survival due to limited effective treatments and lack of predictive markers for selecting the optimal therapy for each patient. Here, we propose the use of an innovative “lab- in- a- patient” device, smaller than a grain of rice, that can be inserted directly into a patient’s tumor for rapid drug screening. Our study is the critical first step toward determining if the implantable microdevice may help select what experimental drugs should be tested in patients and ultimately help chose which approved cancer drug is most effective to treat a patient’s cancer.